NRG Oncology NCORP Research Base-BIQSFP

The objective of this proposal is to establish and maintain the NCORP (National Community
Oncology Research Program) for the NRG Oncology research base. The NRG NCORP is the
result of aligning the legacy CCOPs (Community Clinical Oncology Programs) from three NCI
Cancer Cooperative Groups: NSABP, RTOG and GOG. These groups together have over
almost 100 years of combined experience serving as CCOP Research Bases. NRG NCORP,
comprised of a multi-disciplinary team of investigators and patient advocates, is poised to carry
out the objectives of: 1) designing and conducting cancer prevention, control and screening
clinical trials; 2) designing and embedding patient reported outcomes in both primary NCOPR
trials as well as NRG therapeutic trials 3) designing and conducting cancer care delivery
research; 4) enhancing community access to treatment and imaging trials conducted under the
National Clinical Trials Network (NCTN) and 5) conducting primary intervention trials and
integrating health disparity research questions into cancer care delivery research and treatment
trials. To allow NRG NCORP to meet these goals, the group will: participate fully in NRG
Oncology leadership and will determine the scientific direction and prioritization of the NRG
NCORP activities and resources and oversee the translational research, clinical trial activities,
and correlative studies related to the aims of NRG NCORP. With the NRG Statistical and Data
Management Center (SDMC), this team will provide efficient, methodologically up-to-date trial
design with a focus on NCORP specific needs such as patient-reported repeated longitudinal
assessments and cluster-randomized designs. NRG NCORP will provide study monitoring,
reporting, and analysis; build an infrastructure to support our cancer care delivery research
agenda; provide comprehensive data management quality control and quality assurance
programs to ensure high data integrity and timely data for analysis; leverage cutting edge
information technology emphasizing security, timeliness, and efficiency of data collection and
management; providing RT credentialing and quality assurance; and provide education and
training for institutional Clinical Research Associates, Study Chairs, local Principal Investigators
and others involved in the NRG NCORP research agenda. Further, to accomplish these aims
NRG NCORP will engage fully with NCI-designated NCORP community physicians and patient
advocates as well as the NCI and other NCI-sponsored entities (cooperative groups, cancer
centers, SPOREs) to collaborate across the NCTN to improve cancer prevention and control,
cancer care and outcomes, and quality of life for patients affected by cancer.

Public health relevance
SYMPTOM SCIENCE/QOL Study Checklist 1. The Symptom Science/QOL study application has been discussed with DCP staff and it has been determined that the collection of data requires resources beyond the usual DCP funding. YES DCP staff member: Brandy Heckman-Stoddard, PhD Date: July 10, 2024 Please attach the DCP-provided letter to this document 2. GENERAL INFORMATION BIQSFP STUDY TITLE: Real Time Integral Neurocognitive Function (NCF) Testing in NRG-CC017 PROTOCOL NUMBER: NRG-CC017 (formerly NRG-CC2403) BIQSFP STUDY PI: Jeffrey S Wefel, PhD, ABPP LAB/SITE: University of Texas MD Anderson Cancer Center EMAIL: [email] PHONE: 713-563-0514 3. TOOL OR INSTRUMENT SUMMARY INFORMATION: Test Focus of Measurement Standard of Care Test Completion Timepoint(s) Test Interpretation Timepoint(s) Total # of Tests Proposed Hopkins Verbal Learning Test - Revised Episodic Memory SOC Registration, Month 1, 3, 5, 7, 9 post-RT Real time, All time points 2665 Trail Making Test, Part A Psychomotor processing speed SOC Registration, Month 1, 3, 5, 7, 9 post-RT Real time, All time points 2665 Trail Making Test, Part B Executive Function SOC Registration, Month 1, 3, 5, 7, 9 post-RT Real time, All time points 2665 MAE Controlled Oral Word Association Verbal Fluency SOC Registration, Month 1, 3, 5, 7, 9 post-RT Real time, All time points 2665 4. For each tool/instrument, identify whether it is INTEGRAL or INTEGRATED (Real Time or Non-Real Time). This BIQSFP application proposes to conduct serial, longitudinal neurocognitive function (NCF) testing using the Clinical Trial Battery (CTB) as a real-time integral study outcome. The CTB is composed by the Hopkins Verbal Learning Test – Revised (HVLT-R), Trail Making Test (TMT), and Controlled Oral Word Association (COWA). 5. State the symptom science/QOL hypothesis(es) and its scientific foundation. Specify the study endpoint(s). NRG-CC017 (formerly NRG-CC2403) is a proposed phase III randomized trial comparing standard- delivery radiation therapy (RT) to temporally-modulated pulsed RT (TMPRT) in the treatment of adult patients with newly diagnosed, MGMT promoter unmethylated glioblastoma (GBM). TMPRT is hypothesized to have lower risk of neurotoxicity. The primary endpoint of the phase III is time to NCF failure as measured by the CTB. Surveys of patients with newly diagnosed high-grade gliomas indicate a stronger emphasis on QOL when deciding on treatments, with approximately 80% prioritizing QOL over survival and the majority of patients listing NCF decline as their most critical concern (Helfer et al. 2016, Gabel et al. 2019). There is both preclinical and clinical evidence that TMPRT may be associated with less NCF decline. Specifically, experiments with an orthotopic murine GBM xenograft model demonstrated that TMPRT can achieve superior tumor control, induce fewer bone-marrow-derived myeloid progenitor cells in the tumor microenvironment, cause less neuronal death, and reduce micro-vascular injury compared to standard RT, with or without concurrent TMZ (Park et al. 2011, Dilworth et al. 2013, Lee et al. 2013). A recent single-institution, single- arm prospective phase II study treated 20 adult patients with newly diagnosed GBM using TMPRT and concurrent TMZ and compared survival outcomes to an external cohort of GBM patients treated with standard RT and TMZ from the same institution. The TMPRT treated MGMT-unmethylated GBM group demonstrated superior median OS compared to the standard RT cohort (median 20.6 vs 12.8 months, p = 0.13, respectively) with no significant deterioration of verbal memory (HVLT-R) during two years of follow-up (Almahariq et al. 2021). Due to the limitations of small single-arm phase II studies, it is essential to validate the potential of TMPRT to maintain NCF in a more robust randomized setting. Considering the prior preclinical and single-arm phase II data, we anticipate that TMPRT will prolong time to neurocognitive decline through reduced normal tissue injury. 6. Identify the SYMPTOM SCIENCE/QOL instrument(s) to be used to test each hypothesis, the basis for choosing each instrument, and the timing of the assessments. CTB NCF Tests: The CTB NCF tests (i.e., HVLT-R, TMT, and COWA) are standardized neuropsychological tests widely used in clinical practice that assess cognitive domains of interest in brain tumor patients (i.e., memory, executive function, psychomotor speed). They are sensitive to the impact of cancer and the neurotoxic effects of cancer treatment, feasible in clinical trial settings, and are associated with survival time, quality of life, and functional independence (Meyers et al. 2004, Li et al. 2008, Chang et al. 2009, Sun et al. 2011, Wolfson et al. 2011, Gondi V 2018, Noll et al. 2018). The CTB of NCF tests requires approximately 30 minutes to complete and are a critical objective, patient-centered, functional clinical outcome assessment recommended by the International Cognition and Cancer Task Force (ICCTF)(Wefel et al. 2011) and Response Assessment in Neuro-Oncology (RANO) group (Lin et al. 2013, Alexander et al. 2018, Camidge et al. 2018). The CTB NCF tests have been previously used to measure NCF in patients with GBM in multiple cooperative group trials including NRG/RTOG 0525, NRG/RTOG 0825, NRG/RTOG 3508, NRG-BN001, and NRG-BN007. As a real time integral study outcome, patients will complete NCF testing using the CTB at registration, one month after RT, and every 2 months thereafter until month 9 at the same time points that imaging studies of the brain and clinical staging evaluations are performed as per standard clinical care. This allows us to evaluate the differential impact of treatment effects versus progressive disease in the brain on NCF test results. 7. For each instrument, document its validity, reliability, and responsiveness in the selected patient population. Specify the minimum important difference (MID) or metric for clinically- significant change. Psychometric properties: The CTB NCF tests are reliable, valid, and widely used in clinical practice (Ruff et al. 1996, Benedict et al. 1998, Tombaugh 2004). Responsiveness: In recent trials in the brain met population these tests have demonstrated the ability to detect differential neurotoxicity associated with (a) different doses and schedules of prophylactic cranial irradiation (PCI) in small cell lung cancer (Wolfson, Bae et al. 2011), (b) upfront treatment with PCI versus surveillance in NSCLC (Sun, Bae et al. 2011), (c) WBRT versus stereotactic radiosurgery for patients with brain metastases (Chang, Wefel et al. 2009, Brown et al. 2016, Brown et al. 2017), and (d) WBRT versus hippocampal avoidance WBRT (Gondi et al. 2014, Brown et al. 2020). They are sensitive to the impact of cancer and the neurotoxic effects of cancer treatment, feasible in clinical trial settings, associated with survival time, quality of life, and functional independence (Meyers, Smith et al. 2004, Li, Bentzen et al. 2008, Chang, Wefel et al. 2009, Sun, Bae et al. 2011, Wefel et al. 2011, Wolfson, Bae et al. 2011, Brown et al. 2013, Gondi, Pugh et al. 2014, Brown, Jaeckle et al. 2016, Brown, Ballman et al. 2017, Brown, Gondi et al. 2020). Metric for clinically significant change: The established metric for clinically significant change, which has been used in numerous prior contemporary trials (Chang, Wefel et al. 2009, Sun, Bae et al. 2011, Wefel, Cloughesy et al. 2011, Wolfson, Bae et al. 2011, Armstrong et al. 2013, Gilbert et al. 2014, Freedman et al. 2016, Brown, Gondi et al. 2020) is the Reliable Change Index (RCI) (Jacobson and Truax 1991). The RCI is derived from the standard error of measurement of each test and represents the 90% confidence interval for the difference in raw score from baseline to the next assessment that would be expected if no real change occurred: RCI = 1.64(standard error of difference), where standard error of difference = [2(standard error of measure2)]1/2, and standard error of measure = standard deviation1[(1 − rxy)1/2] NCF failure is defined as a decline in NCF using the reliable change index (RCI) on at least one of the following tests: HVLT-R Total Recall, HVLT-R Delayed Recall, HVLT-R Delayed Recognition, TMT Part A, TMT Part B, or COWA (Jacobson and Truax 1991, Chelune et al. 1993). This endpoint will be evaluated at each NCF testing interval. 8. Please address adjustment for multiplicity. Regarding the significance level, please state what definition was adopted. Regarding power, state what definition of power with multiple testing was adopted. Sample Size Consideration: Due to the competing risk of death, we will utilize Pintilie’s method to estimate the sample size (Pintilie 2002), based on data from NRG/RTOG-0825 and NRG-CC001. For patients aged 65 or older with unmethylated GBM, NRG/RTOG-0825 observed a 6-month NCF failure rate of 80%, accompanied by a 12% competing risk of death. For younger patients, the 6-month NCF failure rate is 66%, with a 4% competing risk of death. Assuming at least 50% enrollment of older patients (we will cap enrollment of younger patients to be ≤ 50%), we will assume an average 6-month NCF failure rate of 73% for the standard-RT arm of the trial, with an 8% competing risk of death. NRG- CC001 was designed to detect an 11% absolute difference in NCF failure at 6 months between treatment arms. Thus, we hypothesize a similar 11% absolute difference in NCF failure at 6 months for our trial, aligning with what constitutes a clinically meaningful difference in the prior practice-changing trial comparing two different RT techniques. To achieve an 80% statistical power with a two-sided alpha of 0.05 using Pintilie’s method, it will require a total of 274 events across both arms. The total sample size required is the number of events required divided by the probability of NCF failure, resulting in 317 patients. To account for potential non-compliance of NCF testing and consent withdrawal, the sample size will be increased by 20%. Thus, a total of 398 patients will need to be accrued for NCF testing to ensure 317 evaluable patients. Given that only 64% of patients registered to step 1 will meeting eligibility requirements to proceed to randomization, approximately 675 patients need to be registered to step 1 to ensure 398 are randomized. Statistical Analysis Plan: NCF failure is defined as a decline in NCF using the reliable change index (RCI) on at least one of the following tests: HVLT-R Total Recall, HVLT-R Delayed Recall, HVLT-R Delayed Recognition, TMT Part A, TMT Part B, or COWA (Jacobson and Truax 1991, Chelune et al. 1993). This endpoint will be evaluated at each NCF testing interval. To estimate the median time to NCF failure, we will use the cumulative incidence approach, accounting for the competing risk of death. Gray’s test will assess statistically significant differences in the distribution of NCF failure times (Gray 1988). The cause-specific Cox proportional hazards regression model will analyze the impact of stratification variables and baseline characteristics (such as race and ethnicity) on the time to NCF failure. Since the primary endpoint does not include any NCF tests after a patient’s decline, the impact of missing data, which is anticipated to increase over time, will be minimized. Additionally, a sensitivity analysis will be conducted. Alive patients without a failure whose first missed NCF test was due to neurological disability will be considered a failure. All other alive patients without a failure will be censored at their first missed visit. 9. Describe any included objective correlates that enhance the patient-reported outcomes data. Not applicable – NCF testing is an objective, performance-based outcome. 10. Explain how patient non-compliance, missing data and/or early death will be handled in the analysis. NCORP and NRG have successfully conducted numerous large, randomized trials using the CTB for serial NCF testing. All standard monitoring procedures will be applied to monitoring and ensuring patients complete NCF testing at the prespecified time points. Noncompliant sites will be contacted and reminded that this is a mandatory component of the trial. NRG has also implemented tools for setting up calendar reminders, automatic reminder and past due emails to ensure timely data collection. NRG has two part- time staff dedicated to monitoring patient compliance on patient-reported outcomes and NCF. From 7/1/2022 to 3/1/2024, PRO and NCF compliance has improved from 74% to 85.7% across all NRG trials, and delinquency has been reduced from 10.2% to 0.5%. Our collective experience is that the most crucial factor for good compliance is educating and constantly reinforcing institutional principal investigators (PIs) that timely NCF test completion is essential for the scientific validity of the study and its impact on site performance auditing. Therefore, the study team will review the compliance data monthly. Dr. Jeffrey Wefel (Neurocognitive Co-Chair) has developed training materials to educate site staff on the significance of NCF testing and how to interact with patients who are developing increasing deficits to maximize the acquisition of test results over time. The trained and certified test administrator selects a test completion code for every test with every patient indicating the test was completed or the reason a test was not completed or was discontinued such as discontinued due to the severity of neurologic disability. This permits us to use worst score data imputation methods and/or proration methods to reduce missing data. We will address missing data by adjusting analyses accordingly, such as incorporating differences in pre-treatment characteristics between patients with missing and completed tests into models. Additionally, a sensitivity analysis will be conducted, censoring patients at their first missed visit. 11. How will visually-impaired patients be accommodated when completing the test(s)? Patients with marked sensory deficits (ie, blindness, mutism) prohibiting test completion will be excluded from the study. These conditions are extremely rare in this patient population. Patients with reduced neurologic function secondary to their disease and/or treatments will be included, as changes in function relative to the pretreatment baseline are captured and analyzed as the outcome of interest. 12. Describe the procedures for data collection and data monitoring including the training of data collection personnel. See Appendix 1 13. Provide turn-around-time for reporting instrument results to clinical PI. A maximum of five business days from receipt of test forms at MDACC to reporting of results of the NCF testing is expected. However, the MDACC past experience on these trials suggests that many cases will be completed in less time. The timeline presumes that no queries to sites are required or that queries are addressed by the site within this timeframe. Test results are not provided to treating physicians but are entered into the central study database. 14. BUDGET A. Include a budget that clearly details the direct and facilities and administrative costs requested using the PHS 398 budget form along with a narrative justifying each requested cost. PHS 398 budget and narrative is attached. Dr. Wefel is a board-certified clinical neuropsychologist, Professor and Section Chief of Neuropsychology at UT MD Anderson Cancer Center, and Neurocognitive Chair of this and many other multi-site cooperative group clinical trials. He will provide the expertise in training, certification, central review and scoring, data management, and supervising the Neurocognitive Coordinator in his lab. Dr. Wefel’s lab equipment includes multiple password protected, server-based computers with a full complement of software packages necessary for all trial related activities as well as scanners and fax machines. B. Include cost per test. The HVLT-R and COWA are owned and copyright protected by Psychological Assessment Resources, Inc. We will contract with PAR to obtain permission to adapt the case report form and use the tests in this trial including creating and using training materials, creating and distributing study manuals, uploading completed forms for review, a digital IP delivery fee and an administrative fee. We will request usage for 675 patients at registration and for 398 patients at timepoints 2-6 for a total of $19,354.12. The TMT does not have an associated fee for use. C. Include cost comparisons to justify the site(s) chosen to complete the test. There are no alternative vendors for the neuropsychological tests. D. Identify potential cost-sharing approaches for the test, as well as cost comparison and justification for academic vs. commercial settings, as applicable. The research testing of NCF, in particular testing by non-licensed psychologists (the vast majority of site staff that assist in cooperative group clinical trials of this nature), is not eligible for clinical reimbursement as a form of cost sharing. 15. NIH BIOSKETCH: Include an NIH biosketch for each study Principal Investigator (PI). Form SF424 can be found at: https://grants.nih.gov/grants/forms/biosketch.htm NIH Biosketch attached. References 1. Alexander BM, Brown PD, Ahluwalia MS, Aoyama H, Baumert BG, Chang SM, Gaspar LE, Kalkanis SN, Macdonald DR, Mehta MP, Soffietti R, Suh JH, van den Bent MJ, Vogelbaum MA, Wefel JS, Lee EQ , Wen PY. Clinical trial design for local therapies for brain metastases: a guideline by the Response Assessment in Neuro-Oncology Brain Metastases working group. Lancet Oncol. 2018; 19(1): e33-e42. 2. Almahariq MF, Quinn TJ, Arden JD, Roskos PT, Wilson GD, Marples B, Grills IS, Chen PY, Krauss DJ, Chinnaiyan P , Dilworth JT. Pulsed radiation therapy for the treatment of newly diagnosed glioblastoma. Neuro Oncol. 2021; 23(3): 447-456. 3. Armstrong TS, Wefel JS, Wang M, Gilbert MR, Won M, Bottomley A, Mendoza TR, Coens C, Werner- Wasik M, Brachman DG, Choucair AK , Mehta M. Net clinical benefit analysis of radiation therapy oncology group 0525: a phase III trial comparing conventional adjuvant temozolomide with dose-intensive temozolomide in patients with newly diagnosed glioblastoma. J Clin Oncol. 2013; 31(32): 4076-4084. 4. Benedict RHB, Schretlen D, Groninger L , Brandt J. Hopkins Verbal Learning Test – Revised: Normative Data and Analysis of Inter-Form and Test-Retest Reliability. The Clinical Neuropsychologist. 1998; 12(1): 43-55. 5. Brown PD, Ballman KV, Cerhan JH, Anderson SK, Carrero XW, Whitton AC, Greenspoon J, Parney IF, Laack NNI, Ashman JB, Bahary JP, Hadjipanayis CG, Urbanic JJ, Barker FG, 2nd, Farace E, Khuntia D, Giannini C, Buckner JC, Galanis E , Roberge D. Postoperative stereotactic radiosurgery compared with whole brain radiotherapy for resected metastatic brain disease (NCCTG N107C/CEC·3): a multicentre, randomised, controlled, phase 3 trial. Lancet Oncol. 2017; 18(8): 1049-1060. 6. Brown PD, Gondi V, Pugh S, Tome WA, Wefel JS, Armstrong TS, Bovi JA, Robinson C, Konski A, Khuntia D, Grosshans D, Benzinger TLS, Bruner D, Gilbert MR, Roberge D, Kundapur V, Devisetty K, Shah S, Usuki K, Anderson BM, Stea B, Yoon H, Li J, Laack NN, Kruser TJ, Chmura SJ, Shi W, Deshmukh S, Mehta MP , Kachnic LA. Hippocampal Avoidance During Whole-Brain Radiotherapy Plus Memantine for Patients With Brain Metastases: Phase III Trial NRG Oncology CC001. J Clin Oncol. 2020; 38(10): 1019- 1029. 7. Brown PD, Jaeckle K, Ballman KV, Farace E, Cerhan JH, Anderson SK, Carrero XW, Barker FG, 2nd, Deming R, Burri SH, Ménard C, Chung C, Stieber VW, Pollock BE, Galanis E, Buckner JC , Asher AL. Effect of Radiosurgery Alone vs Radiosurgery With Whole Brain Radiation Therapy on Cognitive Function in Patients With 1 to 3 Brain Metastases: A Randomized Clinical Trial. Jama. 2016; 316(4): 401-409. 8. Brown PD, Pugh S, Laack NN, Wefel JS, Khuntia D, Meyers C, Choucair A, Fox S, Suh JH, Roberge D, Kavadi V, Bentzen SM, Mehta MP , Watkins-Bruner D. Memantine for the prevention of cognitive dysfunction in patients receiving whole-brain radiotherapy: a randomized, double-blind, placebo- controlled trial. Neuro Oncol. 2013; 15(10): 1429-1437. 9. Camidge DR, Lee EQ, Lin NU, Margolin K, Ahluwalia MS, Bendszus M, Chang SM, Dancey J, de Vries EGE, Harris GJ, Hodi FS, Lassman AB, Macdonald DR, Peereboom DM, Schiff D, Soffietti R, van den Bent MJ, Wefel JS , Wen PY. Clinical trial design for systemic agents in patients with brain metastases from solid tumours: a guideline by the Response Assessment in Neuro-Oncology Brain Metastases working group. Lancet Oncol. 2018; 19(1): e20-e32. 10. Chang EL, Wefel JS, Hess KR, Allen PK, Lang FF, Kornguth DG, Arbuckle RB, Swint JM, Shiu AS, Maor MH , Meyers CA. Neurocognition in patients with brain metastases treated with radiosurgery or radiosurgery plus whole-brain irradiation: a randomised controlled trial. Lancet Oncol. 2009; 10(11): 1037-1044. 11. Chelune G, Naugle R, Lüders H, Sedlak J , Awad I. Individual Change After Epilepsy Surgery: Practice Effects and Base-Rate Information. Neuropsychology. 1993; 7: 41-52. 12. Chelune GJN, R. I. , Lüders H, Sedlak J , Awad IA. Individual change after epilepsy surgery: Practice effects and base-rate information Neuropsychology. 1993; 7(1): 41-52. 13. Dilworth JT, Krueger SA, Dabjan M, Grills IS, Torma J, Wilson GD , Marples B. Pulsed low-dose irradiation of orthotopic glioblastoma multiforme (GBM) in a pre-clinical model: effects on vascularization and tumor control. Radiother Oncol. 2013; 108(1): 149-154. 14. Freedman RA, Gelman RS, Wefel JS, Melisko ME, Hess KR, Connolly RM, Van Poznak CH, Niravath PA, Puhalla SL, Ibrahim N, Blackwell KL, Moy B, Herold C, Liu MC, Lowe A, Agar NY, Ryabin N, Farooq S, Lawler E, Rimawi MF, Krop IE, Wolff AC, Winer EP , Lin NU. Translational Breast Cancer Research Consortium (TBCRC) 022: A Phase II Trial of Neratinib for Patients With Human Epidermal Growth Factor Receptor 2-Positive Breast Cancer and Brain Metastases. J Clin Oncol. 2016; 34(9): 945-952. 15. Gabel N, Altshuler DB, Brezzell A, Briceno EM, Boileau NR, Miklja Z, Kluin K, Ferguson T, McMurray K, Wang L, Smith SR, Carlozzi NE , Hervey-Jumper SL. Health Related Quality of Life in Adult Low and High-Grade Glioma Patients Using the National Institutes of Health Patient Reported Outcomes Measurement Information System (PROMIS) and Neuro-QOL Assessments. Front Neurol. 2019; 10: 212. 16. Gilbert MR, Dignam JJ, Armstrong TS, Wefel JS, Blumenthal DT, Vogelbaum MA, Colman H, Chakravarti A, Pugh S, Won M, Jeraj R, Brown PD, Jaeckle KA, Schiff D, Stieber VW, Brachman DG, Werner-Wasik M, Tremont-Lukats IW, Sulman EP, Aldape KD, Curran WJ, Jr. , Mehta MP. A randomized trial of bevacizumab for newly diagnosed glioblastoma. N Engl J Med. 2014; 370(8): 699-708. 17. Gondi V DS, Brown PD, Wefel JS, Tome WA, Bruner DW, Bovi JA, Robinson CG, Khuntia D, Grosshans DR, Konski AA, Roberge D, Kundapur V, Devisetty K, Shah SA, Usuki KY, Anderson BM, Mehta MP, Kachnic LA. Preservation of neurocognitive function with conformal avoidance of the hippocampus during whole-brain radiotherapy (HA-WBRT) for brain metastases: Preliminary results of phase III trial NRG Oncology CC001. Annual Meeting of the American Society for Radiation Oncology (ASTRO), San Antonio, TX.2018. 18. Gondi V, Pugh SL, Tome WA, Caine C, Corn B, Kanner A, Rowley H, Kundapur V, DeNittis A, Greenspoon JN, Konski AA, Bauman GS, Shah S, Shi W, Wendland M, Kachnic L , Mehta MP. Preservation of memory with conformal avoidance of the hippocampal neural stem-cell compartment during whole-brain radiotherapy for brain metastases (RTOG 0933): a phase II multi-institutional trial. J Clin Oncol. 2014; 32(34): 3810-3816. 19. Gray RJ. A Class of K-Sample Tests for Comparing the Cumulative Incidence of a Competing Risk. Annals of Statistics. 1988; 16(3): 1141-1154. 20. Helfer JL, Wen PY, Blakeley J, Gilbert MR , Armstrong TS. Report of the Jumpstarting Brain Tumor Drug Development Coalition and FDA clinical trials clinical outcome assessment endpoints workshop (October 15, 2014, Bethesda MD). Neuro Oncol. 2016; 18 Suppl 2(Suppl 2): ii26-ii36. 21. Jacobson NS , Truax P. Clinical significance: a statistical approach to defining meaningful change in psychotherapy research. J Consult Clin Psychol. 1991; 59(1): 12-19. 22. Jacobson NS , Truax P. Clinical significance: a statistical approach to defining meaningful change in psychotherapy research. J Consult Clin Psychol. 1991; 59(1): 12-19. 23. Lee DY, Chunta JL, Park SS, Huang J, Martinez AA, Grills IS, Krueger SA, Wilson GD , Marples B. Pulsed versus conventional radiation therapy in combination with temozolomide in a murine orthotopic model of glioblastoma multiforme. Int J Radiat Oncol Biol Phys. 2013; 86(5): 978-985. 24. Li J, Bentzen SM, Li J, Renschler M , Mehta MP. Relationship between neurocognitive function and quality of life after whole-brain radiotherapy in patients with brain metastasis. Int J Radiat Oncol Biol Phys. 2008; 71(1): 64-70. 25. Lin NU, Wefel JS, Lee EQ, Schiff D, van den Bent MJ, Soffietti R, Suh JH, Vogelbaum MA, Mehta MP, Dancey J, Linskey ME, Camidge DR, Aoyama H, Brown PD, Chang SM, Kalkanis SN, Barani IJ, Baumert BG, Gaspar LE, Hodi FS, Macdonald DR , Wen PY. Challenges relating to solid tumour brain metastases in clinical trials, part 2: neurocognitive, neurological, and quality-of-life outcomes. A report from the RANO group. Lancet Oncol. 2013; 14(10): e407-416. 26. Meyers CA, Smith JA, Bezjak A, Mehta MP, Liebmann J, Illidge T, Kunkler I, Caudrelier JM, Eisenberg PD, Meerwaldt J, Siemers R, Carrie C, Gaspar LE, Curran W, Phan SC, Miller RA , Renschler MF. Neurocognitive function and progression in patients with brain metastases treated with whole-brain radiation and motexafin gadolinium: results of a randomized phase III trial. J Clin Oncol. 2004; 22(1): 157-165. 27. Noll KR, Bradshaw ME, Weinberg JS , Wefel JS. Neurocognitive functioning is associated with functional independence in newly diagnosed patients with temporal lobe glioma. Neurooncol Pract. 2018; 5(3): 184- 193. 28. Ostrom QT, Price M, Neff C, Cioffi G, Waite KA, Kruchko C , Barnholtz-Sloan JS. CBTRUS Statistical Report: Primary Brain and Other Central Nervous System Tumors Diagnosed in the United States in 2015-2019. Neuro Oncol. 2022; 24(Suppl 5): v1-v95. 29. Park SS, Chunta JL, Robertson JM, Martinez AA, Oliver Wong CY, Amin M, Wilson GD , Marples B. MicroPET/CT imaging of an orthotopic model of human glioblastoma multiforme and evaluation of pulsed low-dose irradiation. Int J Radiat Oncol Biol Phys. 2011; 80(3): 885-892. 30. Pintilie M. Dealing with competing risks: testing covariates and calculating sample size. Stat Med. 2002; 21(22): 3317-3324. 31. Ruff RM, Light RH, Parker SB , Levin HS. Benton Controlled Oral Word Association Test: reliability and updated norms. Arch Clin Neuropsychol. 1996; 11(4): 329-338. 32. Sun A, Bae K, Gore EM, Movsas B, Wong SJ, Meyers CA, Bonner JA, Schild SE, Gaspar LE, Bogart JA, Werner-Wasik M , Choy H. Phase III trial of prophylactic cranial irradiation compared with observation in patients with locally advanced non-small-cell lung cancer: neurocognitive and quality-of-life analysis. J Clin Oncol. 2011; 29(3): 279-286. 33. Taylor BV, Buckner JC, Cascino TL, O'Fallon JR, Schaefer PL, Dinapoli RP , Schomberg P. Effects of radiation and chemotherapy on cognitive function in patients with high-grade glioma. J Clin Oncol. 1998; 16(6): 2195-2201. 34. Tombaugh TN. Trail Making Test A and B: normative data stratified by age and education. Arch Clin Neuropsychol. 2004; 19(2): 203-214. 35. Tsang DS, Khandwala MM, Liu ZA, Richard N, Shen G, Sekely A, Bernstein LJ, Simpson R, Mason W, Chung C, de Moraes FY, Murray L, Shultz D, Laperriere N, Millar BA , Edelstein K. Neurocognitive Performance in Adults Treated With Radiation for a Primary Brain Tumor. Adv Radiat Oncol. 2022; 7(6): 101028. 36. Wefel JS, Cloughesy T, Zazzali JL, Zheng M, Prados M, Wen PY, Mikkelsen T, Schiff D, Abrey LE, Yung WK, Paleologos N, Nicholas MK, Jensen R, Vredenburgh J, Das A , Friedman HS. Neurocognitive function in patients with recurrent glioblastoma treated with bevacizumab. Neuro Oncol. 2011; 13(6): 660- 668. 37. Wefel JS, Vardy J, Ahles T , Schagen SB. International Cognition and Cancer Task Force recommendations to harmonise studies of cognitive function in patients with cancer. Lancet Oncol. 2011; 12(7): 703-708. 38. Wolfson AH, Bae K, Komaki R, Meyers C, Movsas B, Le Pechoux C, Werner-Wasik M, Videtic GM, Garces YI , Choy H. Primary analysis of a phase II randomized trial Radiation Therapy Oncology Group (RTOG) 0212: impact of different total doses and schedules of prophylactic cranial irradiation on chronic neurotoxicity and quality of life for patients with limited-disease small-cell lung cancer. Int J Radiat Oncol Biol Phys. 2011; 81(1): 77-84. Appendix 1 Training of healthcare providers at each participating sites: The healthcare team members (suggest at least two per site: primary and back up administrator: e.g., psychologist, physician, nurse, study coordinator) at each site that are assigned by the site Principal Investigator to be responsible for test administration in this study must be trained and certified by Dr. Wefel prior to administering these tests on any study subjects. Training of test administrators and their certification must be completed prior to site activation. Dr. Wefel and his team have trained and certified several thousand health care providers in the standardized administration of the Clinical Trial Battery to cancer patients participating in cooperative group and pharmaceutical company led clinical trials. The training materials include: • A study-specific training manual (Neurocognitive Test Administration and Training Manual) - this manual describes the nature of the neurocognitive testing including the general procedures and standardized administration instructions for the neurocognitive test battery. • A password protected, web accessible Clinical Trial Battery Training Video - this training video describes and demonstrates the standardized test administration procedures for the neurocognitive test battery. • A Clinical Trial Battery Training Video post-test - a test covering key test administration procedures that is completed after reading the Neurocognitive Test Administration and Training Manual and watching the Clinical Trial Battery Training Video • Practice Clinical Trial Battery test packet • Test Administrator Certification Worksheet Prior to testing a patient, potential test administrators complete the following training steps: 1. Read the Neurocognitive Test Administration and Training Manual. 2. Watch the Clinical Trial Battery Training Video. 3. Complete the Clinical Trial Battery Training Video post test. 4. Complete a practice assessment on a non-patient volunteer using the Practice Clinical Trial Battery test packet. 5. Complete the Neurocognitive Test Completion Page for the practice case. 6. Complete the “Test Administrator Certification Worksheet.” 7. Submit all materials to Dr. Wefel’s team for review and approval. Dr. Wefel will review the training and certification materials. Any procedural errors will trigger a review with the trainee via email and/or teleconference and additional training may be required until competency in test administration can be confirmed. Dr. Wefel may be contacted by sites via email ([email]) for any questions about training or certification. Dr. Wefel will notify the potential test administrator when they are approved to administer the tests to study participants. A certification approval notice will be sent to NRG to ensure that only NRG-CC017 approved test administrator...